Role of Microglial Fractalkine Signaling in Altered Dopaminergic Wiring in FASD

PROJECT SUMMARY/ABSTRACT
Despite public awareness campaigns, Fetal Alcohol Spectrum Disorders (FASD) remain
prevalent due to alcohol consumption by women that are pregnant or of child-bearing
age. Prenatal alcohol exposure disrupts (1) dopaminergic mesocorticolimbic projections
which is likely related to the executive dysfunction, attention deficits, and increased risk
for substance use disorders that characterize FASD, (2) the subpallium, a critical
intermediate target during axon formation, and (3) guidance cues and signaling pathways
that drive axon formation. In this study, we test the hypothesis that binge prenatal alcohol
exposure hinders dopaminergic axon outgrowth in the subpallium through reduced
signaling between dopamine axons and microglial cells via fractalkine. Our experiments
aim to (1) define the developmental timing of alcohol-induced alterations in fractalkine
signaling and (2) determine the role of these alterations in microglial number, activation,
and regulation of dopaminergic axon guidance. To determine the developmental timing
of alcohol effects on fractalkine signaling, we will measure in vivo levels of mRNA and
protein fractalkine (CX3CL1), its receptor (CX3CR1), and resultant cytokines (IL-1β,
TNFα, IL-6, MIP-1α, and MCP-1) before, during, and after microglial guidance of
dopaminergic axons. To visualize alcohol effects on microglial activation in the
subpallium, we will count immunostained microglia and perform 3D reconstructions to
analyze morphology using Imaris and Halo technologies. To measure dopaminergic axon
outgrowth, we will trace tyrosine hydroxylase (TH) immunostained axons. To confirm the
requirement of fractalkine signaling in these effects, we will utilize CX3CR1eGFP/eGFP mice
which serve as functional knockouts of the fractalkine receptor. Our anticipated findings will
reveal the impact of developmental alcohol exposure on cellular and molecular
mechanisms that are required for proper nervous system wiring, an area that is currently
understudied. This work will enhance understanding of neurobiological underpinnings of
neuroinflammation and dampened dopamine function that are observed in human FASD.

Public health relevance
PROJECT NARRATIVE This study will use a preclinical mouse model to investigate the effects of binge prenatal alcohol exposure on dopaminergic mesocorticolimbic projections whose function is dampened in individuals with Fetal Alcohol Spectrum Disorders (FASD). This will be the first study to investigate the effects of alcohol exposure on fractalkine signaling between dopamine neurons and microglia that is important for proper formation of dopaminergic circuits. Our findings will enhance understanding of cellular and molecular mechanisms that could begin to explain the executive dysfunction, attention deficits, and increased risk for substance use disorders that are evident in FASD.